Investigating tRNA biology as a prognostic and oncogenic feature in pancreatic adenocarcinoma

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDAC) is uniquely difficult to treat due to late diagnosis and limited medical
management options for a majority of patients. This is despite a wealth of watershed studies on disease driver
mechanisms over the past decade, highlighting a need for alternative approaches to studying this disease. It is
now clear that PDACs present along a bimodal continuum of transcriptomic subtypes that exhibit distinct
prognoses, and additional work on advanced PDAC models has uncovered that these tumors, though highly
chemoresistant, are sensitive to external amino acid supply through metabolic dysregulation. Transcripts that
define known PDAC molecular subtypes present unique codon biases, suggesting that PDACs are subject to
biologically deterministic codon-level selective pressures. Work from our lab and others has shown that the
abundance of properly aminoacylated transfer RNAs (tRNAs), highly structured and chemically modified non-
coding RNAs, is highly deterministic of mRNA half-life. This mechanism acts through codon-anticodon
recognition and ribosome elongation rate, and alterations of functional tRNA abundance can dictate cellular
functions via concomitant regulation of mRNA stability. Furthermore, a wealth of literature evidence in diverse
cell types across species demonstrates that tRNA regulation can be disease-specific. Thus, tRNAs may likely
serve a key regulatory role in PDAC subtype expression and amino acid sensitivity, given their function in
bridging codon-amino acid pairings during protein production.
As proof of concept, I have strong preliminary evidence that tRNA expression can be highly predictive of disease
stage in a limited cohort of primary colorectal tumor samples. Furthermore, a pilot study of PDACs revealed
widespread tRNA dysregulation, with increased use of cysteine-decoding transcripts, matching existing literature
that PDACs are specifically sensitive to deprivation of this amino acid. In this proposal, I seek to interrogate
linked roles of tRNAs as regulators of mRNA and nutrient availability phenotypes in PDAC. My central hypothesis
is that PDACs specifically regulate tRNA expression to confer cell survival and proliferation advantages and that
tRNA profiling can reveal novel biomarkers for use in clinical decision-making. I will address this hypothesis
through the following aims: Aim 1: Characterize tRNA expression and modifications in primary patient PDACs;
Aim 2: Investigate PDAC tRNA regulation as a driver of tumor cell survival. These aims will be achieved through
a combination of biochemical and high-throughput sequencing approaches using archived patient samples and
established in vitro cell lines. Beyond biological interrogation, this proposal involves novel technical development
in the experimental and analytical application of tRNA sequencing for large patient sample cohorts. This project
would be the first to analyze tRNA gene-specific regulation in cancer, and will be significant in that it may reveal
novel targetable mechanisms of PDAC maintenance and a potent set of disease-associated clinical features that
are likely to inform fundamental cancer biology.

Public health relevance
PROJECT NARRATIVE Pancreatic ductal adenocarcinoma is one of the deadliest solid malignancies, with well-defined transcriptomic subtypes and amino acid dependencies. The study proposed here offers an innovative approach to investigate transfer RNAs as regulators of these phenotypes and robust molecular markers of disease progression. These factors, along with its capacity to elucidate broader mechanisms of cancer biology, underlie the proposal’s significance.